Towards a quantitative understanding of tumor evolution

ABSTRACT
Cancers are dynamic biological entities whose clonal architecture can change under strong selection pressures,
such as exposure to therapy. As tumors progress through different stages, they coevolve with stromal
populations, which in aggregate constitutes a significant challenge in assessing the potential value of new
therapeutic strategies. Recent discoveries by us and other groups have provided a glimpse of the complexity of
the clonal architecture of many tumors, their dynamics under therapy, and their interactions with the immune
system. In most tumors, several sub-clonal populations simultaneously co-exist, and initially minor clones play a
dominant role in subsequent phases of the tumor’s evolution. As clonal and stromal heterogeneity emerge as
driving forces underlying cancer progression and therapeutic failure, there is a critical need for uncovering the
quantitative fundamental principles underlying the evolution of tumors and their dynamic interaction with their
microenvironment. My recent work has shown that tumor evolution does not proceed in a stochastic fashion but
through a highly structured process, and that future dominant subclones can both be identified and targeted. The
quantitative approaches developed by my group in the last few years are particularly tailored to elucidate the
evolutionary patterns of clonal systems under strong selection. The central hypothesis of this proposal is that (1)
tumor and stroma coevolve in an orchestrated fashion, (2) seeding clones can be identified through genomic and
single cell longitudinal sampling, (3) these clones can be targeted, and (4) in order to characterize these clones
we need to develop new quantitative approaches. The overarching goal of the present proposal is to uncover the
mechanisms by which small tumor and stromal populations coevolve and drive tumor progression and the
emergence of drug resistance, using glioblastoma as a paradigm. Quantitative approaches and fundamental
principles of tumor evolution derived from this research will then be applied to other tumor types.

Public health relevance
NARRATIVE Tumors are complex entities that interact and coevolve with non-tumor cells, a major driving force for therapy resistance. This evolution is not random, but follows well-structured patterns. The recent development of single- cell technologies and novel quantitative approaches is creating the opportunity to uncover the principles of this coevolution and to develop therapeutic strategies to address this complexity.